Structural biology of host-pathogen interactions

We are studying Bacterial systems required for pathogenesis, chiefly secretion and motility systems. These two functions are often achieved via a single large apparatus such as in the bacterial flagellar system which is also a protein secretion system. We are using structural biology and functional studies to dissect systems relevant for infection by a variety of human pathogens. Another range of systems we are starting to investigate include protein assemblies associated with uptake of genetic information from the environment and resistance to phages